Uncovering the role of GREM2 in hematopoiesis during homeostasis and in response to myocardial infarction

PROJECT SUMMARY
Immune cells serve a critical role after myocardial infarction (MI) and are necessary for proper wound healing
and tissue repair, where either an impaired inflammatory response or excessive inflammation leads to defects
to recovery of function. Properly balancing this process and understanding the mechanisms which regulate this
process thus have great therapeutic value. We recently discovered that the BMP antagonist Grem2 regulates
inflammatory cell recruitment in the heart after experimental MI. In addition, our laboratory previously published
data showing that Grem2 regulated the levels of circulating leukocytes after myocardial infarction, suggesting
an important, uncharacterized role in the inflammatory response. My preliminary data here also suggest that
Grem2 serves an important role in regulating hemopoiesis in bone marrow BM hemopoietic stem and
progenitor cells (HSPCs) - the cell population known to activate in response to injury. My findings show that
loss of Grem2 during homeostasis leads to shifts in the BM HSPC population that resemble changes after MI,
and concurrent loss of Grem2 after MI leads to even more severe changes. Additionally, this shift is associated
with a myeloid bias present in BM clonogenic progenitors and peripheral blood (PB) leukocytes. Moreover,
patients who possess the GREM2 Q76E variant – a mutation that enhances the proteins inhibitor activity –
demonstrate perturbed hemopoiesis reflected in increased hemopoietic disease risks and shifted CBC lab
values opposite to those observed in our Grem2-/- mice. As this posits a novel role for Grem2 in regulating BM
hemopoiesis both during homeostasis and in response to MI, this proposal will address this knowledge gap by
deepening our understanding of Grem2's role in hemopoiesis. To do so, specific multipotent, oligopotent, and
committed precursor cell populations will be assayed in WT and Grem2-/- BM to identify populations regulated
by Grem2 function. Moreover, absolute cell counts will be measured in order to assess for changes in BM
cellularity, and proliferative capacity of populations that exhibit differences will be measured. These studies will
be supplemented with functional assays using colony forming assays to measure biases in differentiation
potential of progenitor populations upstream of shifted BM cell populations. Detection of aberrant BMP
signaling in these populations along with administration of DMH1, a BMP inhibitor, to reverse phenotypes will
be carried out to determine that consequences arise from defective BMP antagonism. Regulation of HSPC
mobilization by Grem2 will also be explored. Paralleling this, I plan to use genetics and informatics tools to
characterize clinical consequences of altered GREM2 function in patients, focusing on relevant hematopoietic
disease risks and cardiovascular outcomes. The proposed work will provide important new information
regarding the role of BMP signaling inhibition by Grem2 in BM hemopoiesis both during homeostasis and in
response to MI. This knowledge may eventually lead to new strategies to treat human diseases that are
caused by impaired inhibition of BMP signaling.

Public health relevance
PROJECT NARRATIVE In the context of our growing understanding of the important functions served by immune cells after myocardial infarction, my preliminary data demonstrates a critical role of the BMP antagonist Grem2 in regulating bone marrow hemopoietic stem and progenitor cells in homeostasis and in response to cardiac injury and affects the generation of immune cells, and moreover, my analyses show patients with enhanced GREM2 function demonstrate perturbances to hemopoiesis as reflected by disease risks and lab values. To address these findings, this proposal will work to deepen our understanding of Grem2's role in the generation of immune cells. This knowledge will help guide new strategies to improve cardiac recovery after a heart attack and inform underlying defects in patients with GREM2 dysfunction.